Synucleinopathies – Novel Targets in Early Diagnosis, Pathophysiology, and Therapeutic Approach

PROJECT SUMMARY/ABSTRACT
Parkinson's disease (PD), dementia with Lewy bodies (DLB), and multiple system atrophy (MSA) comprise a
group of neurodegenerative diseases that share the pathophysiological mechanism of abnormal aggregation of
alpha-synuclein (αSyn). Promising attempts at disease modification in established synucleinopathies have
failed, raising the important issue that patients who have clinically overt, established disease are too advanced
for disease-modifying therapies to be efficacious. Therefore, strategies have evolved to allow for earlier
disease detection and confirmation which was pursued in our current grant period with focus on pure
autonomic failure (PAF). PAF has more recently been established as one of the synucleinopathies, and is
characterized by isolated autonomic failure without motor or cognitive deficits, representing a pre-motor stage
with high risk of conversion to MSA, PD, or DLB. The main goal of the current grant period was to identify and
validate spinal fluid (CSF) and MRI biomarkers of conversion of PAF to motor synucleinopathies. We have
accomplished that goal by identifying highly predictive mechanism-based CSF and MRI markers in established
synucleinopathies, that when applied to the pre-motor stage can predict conversion and conversion phenotype.
REM sleep behavior disorder (RBD) is a condition with close association with synucleinopathies and frequently
presents as isolated RBD (iRBD) years before motor or cognitive symptoms develop. The relevance and
implications of iRBD as prodromal synucleinopathy has been well recognized, but to date there are no reliable
predictors of conversion, phenotype of conversion, or timing of conversion to an established synucleinopathy.
We have expanded the biomarkers developed to predict PAF phenoconversion to iRBD patients and identified
discrete CSF profiles akin to those seen in PAF and in manifest motor and cognitive synucleinopathies, so that
we are now in a position to test the biomarker potential of these markers at the prodromal stage.
In this renewal, we shall study sleep-study confirmed iRBD patients stratified by baseline CSF biomarker
phenotype (MSA-, PD/DLB, or normal type) along with healthy control subjects with serial clinical evaluations
combined with autonomic, CSF, and MRI biomarker studies. We will enhance the feasibility of reaching
recruitment goals for each biomarker phenotype by enriching recruitment with participants in the North
American Prodromal Synucleinopathy Consortium identified as biomarker phenotype required to reach our
recruitment goals. Secondly, we will continue to follow PAF patients enrolled during the current grant period
who have not yet phenoconverted to solidify the predictive value of developed biomarkers.
The findings from this renewal proposal should result in establishing biomarkers for the pre-motor and
prodromal stages of syncucleinopathies, which may translate to disease-modifying therapy trials standing a
better chance at demonstrating efficacy, and which may eventually even allow for diagnosing selected
neurodegenerative diseases at the preclinical stage.

Public health relevance
PROJECT NARRATIVE The importance of early disease detection in Parkinson's disease (PD), dementia with Lewy bodies (DLB), and multiple system atrophy (MSA) is demonstrated by the failure of promising clinical trials to slow disease progression, quite possibly because those interventions occur when the disease is already established and too advanced. In the current grant period, we have identified highly predictive biomarkers in the spinal fluid and on MRI imaging that allow for predicting a future diagnosis of PD/DLB or MSA when the disease is still at a limited stage without motor or cognitive symptoms or signs. We now propose in this renewal application to apply these promising markers to an even earlier stage, when only sleep abnormalities are present (REM sleep behavior disorder), in order to allow for detection of these neurodegenerative diseases at a prodromal stage.